Microglial-Mediated Glycosaminoglycan Catabolism in MPS VII Neuropathology.

Abstract / Project Summary
The brain's extracellular matrix (ECM) is a three-dimensional milieu that plays a crucial role in synaptic function
and plasticity during development in addition to its regulatory role in axon regeneration and remyelination from
injury. Despite its significance, our understanding of how the content of the major brain ECM components,
glycosaminoglycans (GAGs) and GAG-modified proteins (proteoglycans), are regulated is limited.
Mucopolysaccharidosis VII (MPS VII) is a multi-organelle lysosomal storage disorder caused by the deficiency
of β-glucuronidase (GUSB), resulting in neurodevelopmental delay and broad neurological impairment.
Our preliminary studies using an MPS VII mouse model that is globally deficient in β-glucuronidase enzyme
show prominent intracellular WFA-stained aggregates observed selectively in CD68+ microglia. These results
suggest a critical role of microglia-mediated proteoglycan/GAG catabolism in CNS development. These
findings lead us to hypothesize that the loss of GUSB function in microglia is a key driver of MPS VII
neuropathology. However, there are no existing genetic tools to specifically target and ablate β-glucuronidase
activity in microglia. Additionally, there are no existing biomarkers to assay for non-degraded GAGs
accumulating intracellularly from the loss of β-glucuronidase activity.
The objective of this proposal is to develop new genetic and biochemical tools to test for the importance of
microglia-mediated GAG catabolism in the CNS and its dysfunction as a root cause for MPS VII
neuropathology. In Aim 1 we will develop and validate new genetic tools to conditionally ablate β-
glucuronidase mediated GAG catabolism within microglia and other cells of neural lineage. In Aim 2 we will
measure for non-degraded intracellular GAGs that selectively accumulate in MPS brain tissue. Combining
these newly generated genetic reagents with the biochemical approach to measure non-degraded intracellular
GAGs will allow us to discern and assess microglial mediated GAG catabolism and their dysfunction in MPS
VII neuropathology.

Public health relevance
Project Narrative The development and function of the nervous system are critically regulated by the extracellular matrix, that is largely composed of glycosaminoglycan sugars (GAGs) and GAG modified proteoglycans. MPS VII (Sly syndrome) is an inherited disorder caused by mutations in Gusb, which encodes the enzyme β-glucuronidase, essential for breaking down GAGs. This proposal aims to develop new genetic and biochemical tools to test the hypothesis that microglia play a key role in GAG catabolism within the CNS and that their metabolic dysfunction significantly contributes to MPS VII neuropathology.